Genetic Determinants of Aspergillus host-pathogen interactions

The long-term goal of our work is to reduce the morbidity and mortality associated with Aspergillus infections by
improving outcomes of host-pathogen interactions. Aspergillus fumigatus is the major airborne fungal pathogen
and is responsible for a range of clinical syndromes, the severity of which is dependent on host immune status.
Invasive pulmonary aspergillosis and disseminated infections can occur in severely immunocompromised hosts
and are often associated with mortality rates of up to 90%. In immune competent hosts, A. fumigatus colonization
can lead to chronic pulmonary aspergillosis (CPA), a clinical manifestation with recently defined diagnostic
criteria that impacts upwards of 1.6 million individuals per year. Many individuals with CPA have underlying
respiratory conditions, such as asthma or cystic fibrosis, that are further exacerbated by the presence of the
fungus. Although multiple Pathogen-Associated Molecular Patterns (PAMPs) driving host recognition and
response are known, uncovering novel fungal molecular pathways that could serve as therapeutic targets to
enhance or mask PAMP display and/or biosynthesis could prove useful therapeutic targets to modulate host
response for improved outcomes. To address this, we utilized activation of the inflammasome, a multiprotein
intracellular complex that detects pathogenic organisms to initiate inflammatory responses, as a tool to uncover
Aspergillus mutants with altered abilities to activate host response. We have completed a preliminary screen to
measure IL-1β secretion from a macrophage differentiated human monocyte cell line employing an A. fumigatus
protein kinase disruption library recently generated in our lab. Of 118 protein kinase disruption mutants screened,
we identified seven A. fumigatus protein kinases that either significantly increased (n=2) or decreased (n=5)
inflammasome-dependent IL-1β secretion upon disruption. Strikingly, both of the protein kinase disruption
mutants that induced increased IL-1β release encode phospho-relay sensor histidine kinases (phkA and fhk3),
a sub-class of protein kinases that directly sense environmental and intracellular changes and subsequently
activate stress response signaling. The molecular pathways controlled by PhkA and Fhk3 are unknown, as both
HKs are largely uncharacterized. Although a major consequence of HK signaling is activation of stress responses
pathways that upregulate transcription factor activity to respond to environmental stimuli, the downstream
transcriptional effectors for all A. fumigatus HKs remain undescribed. Our work will delineate A. fumigatus
histidine kinase (HK)-dependent mechanisms of host response (Aim 1) and identify A. fumigatus transcriptional
regulators of inflammasome activation (Aim 2). Through completion of the proposed Aims, we will delineate
fungal molecular pathways mediating Aspergillus-induced host response. This work is essential for future
development of novel therapeutic approaches targeted towards activating protection against invasive infections
or mitigating harmful host-response during chronic infections.

Public health relevance
Aspergillus infections are associated with high morbidity and mortality in both immunocompetent and immunocompromised patients. To reduce the burden of aspergilloses, novel therapies targeted towards activating protective immunity or inhibiting harmful over-inflammation are needed. Our research aims to address this need by deciphering molecular pathways required for regulation of host-pathogen interactions.